Phylogenetic modeling of viral transmission dynamics at the human-wildlife interface in Uganda

Many infectious diseases that threaten humans originated among wildlife, yet we know relatively little
about the real-world ecological conditions that enable spillover events. Despite its importance, identifying
novel viral pathogens and characterizing their transmission dynamics remains difficult because it requires
advanced genetic sequencing technologies, sampling wildlife likely to harbor pathogens of concern to
humans, and sophisticated modeling techniques. We will study red colobus monkeys in Kibale National
Park, Uganda, other nonhuman primates, and people who neighbor these wildlife populations to quantify
transmission dynamics within and between species. Our team will collect behavioral ecology data on red
colobus monkeys living in areas of the forest with different degrees of anthropogenic disturbance and
conduct interviews with people living along the boundary of the park with varying exposure risks for
zoonotic diseases. We will conduct repeat sampling of people and individually identifiable red colobus
monkeys to analyze the gut virome, assess infection with gastrointestinal parasites known to infect both
red colobus and people, discover previously undocumented viral diversity, detect the presence of novel
pathogens of concern to humans, red colobus monkeys, and other primates (e.g. SARS-CoV-2), and
track the evolutionary spread of detected pathogens. To model how red colobus-associated viruses
spread, we will develop new phylodynamic models that allow longitudinal ecological and biogeographical
data to structure time-heterogenous epidemiological event rates. We will also create, test, and distribute
new software for simulation, Bayesian inference, and deep learning-based inference to model how
infectious diseases spread in a wide variety of ecosystem-level transmission scenarios. Our proposed
project will benefit public health and wildlife conservation and expand STEM training in the USA and
Uganda. Working with Ugandan communities, we will co-create solutions to address risks for zoonotic
disease transmission and test mitigation strategies to reduce transmission pathways.

Public health relevance
Many infectious diseases that harm humans originate from wildlife. This research will collect viral genome and gastrointestinal parasite data from red colobus monkeys, other nonhuman primates, and humans at Kibale National Park (Uganda) and develop new statistical analysis methods to quantify what conditions allow viruses to spread within and between the species that share the ecosystem.